Systems Science and Comparative and Cost-Effectiveness Research Training for Nurse Scientists (S2CER2)

Columbia University School of Nursing (CUSON) has been a leader in preparing nurse scientists to conduct relevant, rigorous, interdisciplinary, comparative, and cost-effectiveness health policy research for nearly a decade to inform care delivery across the lifespan and to improve the patient care through our training grant (T32NR014205) and related funding sources. Leaders, preceptors, and trainees of our program have conducted research that has advanced nursing science and health. We will expand on the success and substantial achievements of the prior 10 years with this competitive renewal entitled “Systems Science and Comparative and Cost-Effectiveness Research Training for Nurse Scientists” (S2CER2). S2CER2 aims and training activities are well-aligned with National Institute of Nursing Research’s commitment to supporting nursing science focused on: a) strengthening health care delivery; b) developing and implementing interventions that address conditions of daily living across the lifespan; and c) designing systems and models of care to address clinical, organizational, and policy challenges. Building upon our unique strengths, S2CER2 leverages our leadership team and excellent institutional resources, including the research base of participating faculty, to focus on overcoming structural obstacles to health for everyone. We will provide high-quality, innovative, and relevant training for nurse scientists dedicated to conducting systems, comparative, and cost-effectiveness research with the goal of increasing health for all. Given our success in recruiting and training a qualified cadre of nurses and past program outcomes, we request 3 predoctoral and 4 postdoctoral positions. The specific aims of S2CER2 for Years 11–15 are to: 1. Maintain an administrative structure to support interdisciplinary systems science, and comparative and cost-effectiveness research training to advance health. 2. Recruit and retain a qualified cadre of predoctoral and postdoctoral nurses from different backgrounds, cultures, experiences, and perspectives to conduct interdisciplinary systems science, comparative-effectiveness and/or cost-effectiveness research to advance health and facilitate evidence-based practice. 3. Enhance the knowledge and skills of predoctoral and postdoctoral nurse trainees in the integration of theories and methods relevant to systems science, and comparative and cost-effectiveness to advance health and facilitate evidence-based practice. 4. Evaluate the training program inputs, outputs, and outcomes on an ongoing and annual basis and refine the program as needed. The need for nurse scientists trained to achieve the focus of the S2CER2 aims is greater than ever, and CUSON, with its exceptional resources, is uniquely qualified to lead this innovative program.

Public health relevance
The “Systems Science and Comparative and Cost-Effectiveness Research Training for Nurse Scientists” (S2CER2) research training program will provide nurse scientists with knowledge and skills to conduct interdisciplinary research to advance health. This competitive renewal will support pre- and postdoctoral trainees to conduct research focused on a) improving health care delivery; b) developing and implementing interventions that address conditions of daily living across the lifespan; and c) designing systems and models of care to address clinical, organizational, and policy challenges.